Africa Cancer Leaders Institute

PROJECT SUMMARY
The proposed renewal application for African Cancer Leaders Institute (ACLI) is a “meeting within a meeting”
designed to coincide with conferences organized by the African Organization for Research Training In Cancer
(AORTIC) conference, beginning with the forthcoming, “Cancer in Africa: Implementation, Workforce, and
Opportunities” in Dakar, Senegal, November 3-8, 2023.The ACLI will identify early career researchers, especially
women and individuals underrepresented in global cancer research who are capable of leading interdisciplinary
teams to improve cancer treatment in Africa. The long-term goal of the ACLI is to provide an intellectually
stimulating platform to propel emerging global cancer leaders from Africa and the US to receive support for
innovative cancer research in Africa, and to stimulate an African network for emerging leaders in cancer
research. The ACLI platform will have annual goals and objectives set by the Education and Research Sub-
Committees of AORTIC in collaboration with the ACLI program Organizers. The ACLI will widely solicit
competitive applications from aspiring leaders in Africa and the US. During the past funding cycle, three cohorts
of ACLI participants (60 total) were recruited and participated in AORTIC Conferences in Durban in 2017, Maputo
in 2019 and Senegal in 2022 during a mini-retreat for ACLI members and AORTIC Council Members at the 1st
African Regional Cancer Conference (ARCC) planned and hosted by AORTIC Leadership in West Africa.
Awardees from all cohorts were invited to participate and 21 attended in person. It was gratifying to note
enthusiastic participation by investigators from West Africa, especially those from French and Portuguese
speaking countries. Most of the ARCC lectures were given by ACLI participants and researchers working in
Africa who reported having received 6 NIH and 5 foundation grants. ACLI participants were unanimous in
endorsing the need for a regional conference every other year that will provide greater capacity building
opportunities and more succinct leadership programing for ACLI. For this renewal application, 10 Emerging
Leaders will be fully-funded for travel to attend the AORTIC conference and participate in ACLI activities.
Five emerging Leaders from high-income countries with meritorious abstracts and application will be
selected for Merit travel award in order to continue to forge professional relationships and foster peer
mentorship. ACLI participants will mostly network in groups of 6-8 with conversations on specific topics
facilitated by Faculty and attend scientific sessions. For peer mentoring, sessions will be arranged for ACLI
participants to discuss and evaluate concepts presented at the conference to enhance learning and career
development experience. Each new ACLI participant will be asked to prepare a brief 15-minute overview of
career accomplishments and plans for their career development activities. We will continue to track a number of
metrics including conference evaluations, career landmarks, publication records and the number of ACLI
members who compete successfully for Africa focused NIH/NCI grants e.g K43, K07, K23, R21 etc.

Public health relevance
NARRATIVE The African Cancer Leaders Institute (ACLI) is a “meeting within a meeting” designed to coincide with the AORTIC 2023 conference, “Cancer in Africa: Implementation, Workforce, and Opportunities” in Dakar, Senegal, November 3-8, 2023.The ACLI provides an intellectually stimulating platform to propel emerging global cancer leaders from Africa and the US with intensive trainings, mentorship, and networking opportunities with the goal to foster innovative cancer research leadership in Africa. For this renewal application, we have incorporated a mini-Retreat at a African Regional Cancer Conference where ACLI Alums can interact with AORTIC Council Members and participate in planning future AORTIC activities.